2024 Environmental Endocrine Disruptors Gordon Research Conference and Gordon Research Seminar

Project Summary
This application requests funds to support the 14th Gordon Research Conference on Environmental
Endocrine Disruptors (GRC-EED), to be held June 23-28, 2024 and the accompanying Gordon Research
Symposium (GRS) for trainees, to be held June 22-23, 2024 at the Renaissance Tuscany Il Ciocco Resort in
Barga, Italy. The conference theme is The role of EEDs in planetary health and planetary boundaries and the
unifying goal of the conference is to present cutting-edge results, illustrating the depth and breadth of work
being done to study EEDs, in a way that is accessible across disciplines and beyond the boundaries of
science. The GRC-EED will have 9 sessions: The first session will have two keynote talks focused on a high-
level view of human exposures to EEDs and their health consequences. Next, there will be scientific sessions,
each focused around a broad topic such as “Mechanisms of EED Action”, “Characterizing human exposure to
EEDs”, “Breaking down the walls between human and experimental toxicology” and “Enhancing
interdisciplinary and multistakeholder collaboration in the EED field”. The final session will highlight “big
picture” issues related to “Planetary Health: Global Solutions for Global Problems”. The GRC-EED will also
include two poster sessions, and speakers will be selected from the submitted abstracts to also give short
talks.
Prior to the GRC-EED, the GRS will provide an outstanding, intimate setting with opportunities for
trainees to network and present their work in a supportive environment. The GRS will include a keynote
speaker and a discussion panel with four members representing different career paths (government, industry,
academia and non-profits) and additional speakers will be selected from trainee abstracts.
The GRC-EED and GRS are intended to have presentations by leading scientists highlighting new
information from researchers who work across several disciplines including toxicology, endocrinology,
neuroscience, exposure science, public health, ecology, physiology, and epidemiology, among others. The
conference has been organized to integrate these various fields throughout the meeting to permit open and
informative discussions, introduce new paradigms and lead the field forward towards novel discoveries. The
GRC represents a unique venue for promoting the exchange of scientific ideas through its format of extensive
discussion periods in each session, ample free time to encourage informal interactions, and exchanges at
poster sessions that will allow attendees to present their latest research findings in a collegial atmosphere.

Public health relevance
Project Narrative The 14th Gordon Research Conference on Environmental Endocrine Disruptors will bring together basic and translational scientists, clinicians, and public health advocates across scientific disciplines to increase collaboration and discussions to foster cross-fertilization in the field. The theme of this conference, the impact of environmental endocrine disruptors on planetary health and planetary boundaries, will allow researchers to present cutting-edge results, illustrating the depth and breadth of the field, in a way that is accessible across disciplines. The primary objective of this conference is to remain the preeminent place for researchers at every career stage to learn about the latest advancements and exchange scientific ideas relevant to the endocrine disruptors.